Administrative Core

Core A (Administrative Core, Henke) provides administrativesupport to all Sections of the Program Project. This core is responsible for coordination and processing of all requests related to personnel and financial matters. The Program Director assumes administrative and scientific leadership to assure effective coordination for all scientific Projects and Cores. In addition, he is responsible for quality assurance of this scientific program. Other features of the Core include the maintenance of personnel records, processing of supply orders, maintaining financial records and statements, and other appropriate administrative support. In addition, this Core coordinates requests for and facilitates the arrangements for seminars, visits by scientists from other institutions, and related matters. This Core will coordinate and foster scientific exchange amongst investigators within the PPG. Specifically, this core will organize visits to the University of Minnesota for project leaders from outside the University of Minnesota (Dr. Sem Phan, and Dr. Zea Borok). The core will arrange meetings of the Internal and External Scientific Advisory Committees. The Core Director (Dr. Craig Henke) is assisted by Michelle McGraw, Administrative Associate and Grant Manager. Biostatistics support for the Projects will be provided by Dr Hongfei Guo, an Assistant Professor in the Division of Biostatistics. Dr. John Connect, Professor and Head of the Division of Biostatistics, School of Public Health at the University of Minnesota will supervise Dr. Guo and provide expertise in biostatistical design and analysis. RELEVANCE (See instructions):